Towards the discovery of Nurr1-RXR modulators

The nuclear receptor transcription factor Nurr1 is essential for the regulation and maintenance of several
important aspects of mammalian brain development and homeostasis. Nurr1 regulates a gene program that
controls the development and function of dopaminergic neurons, which are critical for motor neuron function
and control of movement that degenerates in patients with Parkinson’s disease. Furthermore, recent studies
show that Nurr1 is an important factor in regulation of neuroinflammation and the accumulation of Amyloid beta
(Aβ) that occurs in the pathogenesis of Alzheimer’s disease patients. These and other studies implicate small
molecule activation of Nurr1 as a potential therapeutic strategy in Alzheimer’s disease, Parkinson’s disease,
and other aging-associated neurodegenerative and dementia disorders characterized by a loss of neuron
function. However, screening campaigns to discover Nurr1 binding and/or transcriptionally activating small
molecules have produced limited Nurr1-specific compound scaffolds and have not yet provided potent, high
affinity Nurr1-specific ligands. An alternative approach to regulate Nurr1 activity that has gained momentum is
targeting Nurr1-RXR heterodimer complexes via small molecule ligands that bind to the RXR LBD. In this
project, we will build on our strong preliminary data and develop biochemical and cellular assays that detect
ligand-induced changes in Nurr1-RXR activity. The successful outcomes of our studies will provide a platform
to screen, discover, and characterize Nurr1-RXR selective ligands that can be used as chemical tools to study
Nurr1-RXR modulation in models of Alzheimer’s disease, Parkinson’s disease, and other aging-associated
neurodegenerative and dementia disorders.

Public health relevance
Synthetic drug-like molecules targeting Nurr1-RXR nuclear receptor heterodimers hold promise in the treatment of aging-associated neurodegenerative and dementia disorders characterized by a loss of neuron function. The objective of this project is to lay the groundwork to discover and characterize new Nurr1-RXR selective drug-like molecules. Successful outcomes of our work will have a positive impact on future drug discovery efforts that could result in novel treatments for Alzheimer’s disease, Parkinson’s disease, and other aging-associated neurodegenerative disorders.